Defining the role of tuft cells in allergic airway disease

Project Summary/Abstract
This proposal describes a 5-year plan to achieve the candidate’s goal of becoming an independent physician-
scientist studying interactions between the airway epithelium and the type 2 immune system. With a
comprehensive plan of coursework and hands-on training, guided by a skilled scientific advisory and mentoring
team, and situated within the exceptional intellectual environment at UCSF, Dr. Kotas will utilize established,
specialized tools and techniques from her mentor’s lab and become newly proficient in primary airway epithelial
culture, translational studies using human tissues, and state-of-the-art transcriptional techniques. By the end of
this project, she will possess a unique toolset that will differentiate her from her mentor and will have sufficient
data to launch an independent research group while contributing new knowledge to the scientific community.
The investigative purpose of this proposal is to elucidate how tuft cells—specialized epithelial cells with poorly
understood function—influence the behavior of nearby epithelial and immune cells during chronic type 2 airway
inflammation. As chronic allergic inflammation is the underlying cause of morbidity and mortality in millions of
patients with diseases such as nasal polyps and type 2 high asthma, an improved understanding of the cells and
molecules that contribute to these pathologies is needed to design new therapies. In preliminary data, Dr. Kotas
finds that tuft cells in the chronically allergic upper airway environment adopt a distinct “allergic” phenotype
characterized by increased production of prostaglandin E2 (PGE2). This is concurrent with a transcriptional
signature of PGE2 on the neighboring epithelium, while in vitro, PGE2 stimulates epithelial fluid secretion.
Transcriptional signatures of allergic tuft cells and PGE2 activation are also observed in the bronchus in type 2
high asthmatics, suggesting similar pathology throughout the allergically-inflamed respiratory tract. These
findings urge further examination of tuft cells and tuft cell-derived PGE2 in allergic airway disease.
In this proposal, Dr. Kotas will build upon her preliminary data to probe the effects of tuft cells and PGE2 on
airway homeostasis. Aim 1 will use mouse cells in vitro and whole animal modeling in vivo to examine tuft cell-
dependent alterations mucociliary movement and airway surface liquid composition. Aim 2 will examine the
effects of tuft cells and PGE2 on the type 2 immune system in mouse models of allergic airway disease. And
Aim 3 will return focus to human subjects and determine the phenotype and activation state of tuft cells in the
lower airway in type 2 high asthma. Together, the proposed experiments will improve our fundamental
understanding of how tuft cells contribute to allergic airway disease, and may identify new molecular and cellular
targets for future therapy.

Public health relevance
Project Narrative During chronic allergic airway inflammation, rare chemosensory cells called tuft cells produce prostaglandin E2 (PGE2), which I hypothesize modifies mucus movement and airway inflammation, contributing to diseases such as asthma and nasal polyps. My proposal will use mouse modeling and cell culture to understand how tuft cell-derived PGE2 orchestrates immune and epithelial functions in the airway during allergic inflammation, and then investigate whether the same processes contribute to asthma in humans. These studies will advance fundamental knowledge of airway biology and may identify new therapeutic targets to treat millions of patients suffering with chronic allergic airway diseases.